C5-Circular RNA's and immune sensitization

Animal and clinical studies support the biological vulnerability to chronic central nervous system (CNS) diseases
in FASD populations is driven by dysfunctional CNS-immune interactions, which include signaling and
transcriptional regulatory factors often engaged following toll-like 4 (TLR4) immune receptor activation, and may
underlie cognitive deficits precipitated by typical stressors; a secondary insult or “second hit”. Frequently, these
problems do not manifest until adolescence or early adulthood. One potential mechanism driving CNS immune
dysfunction as a consequence of prenatal alcohol exposure (PAE) (“first hit”) may involve circular RNAs
(circRNAs), which are brain-enriched non-coding RNAs capable of acting as diverse regulators of gene
expression and immune function via both transcriptional and post-transcriptional mechanisms. We recently
published that a subset of circRNAs is dysregulated in the prenatal brain as a result of PAE. Preliminary data
show dysregulated circRNAs from PAE in rodent blood and spinal cord, and sex differences were present
between elevated proinflammatory immune factors in the rodent female amygdala when stimulated by a “second
minor hit”, an acute stressor, with PAE. These immune factors overlap with the intracellular TLR4 activation
pathway thus narrowing the breadth of immune factors that may be dysregulated by PAE following a secondary
challenge. Leveraging clinical data from adolescent children with an FASD (Component 3; current Phase III
P50) who are evaluated for cognitive regulation, the goals of Component 5 is to evaluate and correlate the impact
of PAE on the expression of a subset of circRNAs, and associated mRNAs and proteins from (1) adolescent
mouse blood and brain regions that support cognitive function involving working memory following minor
challenges, and (2) saliva and blood of adolescent children with an FASD undergoing specific cognitive tasks.
The overarching hypothesis of Component 5 is that a subset of circRNAs is dysregulated by PAE, creating
brain immune sensitization that: 1) is necessary and sufficient for cognitive deficits precipitated by minor
challenges in adolescent mice, and (2) predicts cognitive deficits and stress perception in human adolescents
with FASD. Sex differences are integrated into the three Aims proposed to test this hypothesis. Component 5 of
Phase III will complement other research components by evaluating middle adolescent cognitive function of
mouse offspring with PAE using age-appropriate cognitive tests, which may predict and complement cognitive
deficits that develop in young adulthood, as assessed by other components of Phase III. CircRNA, mRNA and
protein analyses from Component-3 adolescent mice can be correlated with measured neuroimmune factors
from brains of behaviorally validated young adult mice from other components. Newly identified circRNAs that
regulate associated mRNA/protein immune factors will be correlated with Component 3’s clinical study of
cognitive function in human adolescents. CircRNA biomarkers for FASD populations may emerge. Results may
identify novel targets to mitigate the risk of neuroimmune and cognitive dysfunction in individuals with FASD.

Public health relevance
Project Narrative Emerging evidence from both preclinical and clinical studies support that the biological vulnerability to chronic central nervous system (CNS) dysfunction in FASD populations is driven by aberrant CNS-immune interactions rendering them particularly susceptible to developing cognitive disabilities during the period of adolescence, often manifesting after secondary challenges such as stress or immune challenges. While the underlying mechanism of adolescent cognitive deficits from prenatal alcohol exposure (PAE) is unknown, the proposed research will identify whether non-coding circular RNAs underlie sensitized CNS-inflammatory immune signaling pathways, potentially inclusive of TLR4-associated factors, from PAE that leads to cognitive deficits. Exploring these novel molecular targets in preclinical models along with leveraging clinical data from adolescent children with FASD, will provide a foundation to develop future therapeutic targets to treat adolescent cognitive deficits as well as identify biomarkers of adolescent cognitive dysfunction for early intervention to mitigate the impact PAE exerts on cognitive function.